Optimizing a Novel AAV Vector to Selectively Influence Seizure Networks In Vivo

Abstract
Approximately 3 million Americans have a diagnosis of epilepsy (Hirtz et al., 2007) where approximately
one third of this population experience inadequate seizure control (Cascino, 2008; Kwan and Brodie, 2000;
Braakman et al., 2011). Based upon the fact that chronic seizures compromise the blood-brain barrier (BBB) in
areas of seizure activity, we discovered a novel chimeric AAV vector, clone 83, that selectively crossed the
seizure compromised BBB after intravenous administration (Gray et al., 2010). Unfortunately, the amount of
therapeutic gene expression was not sufficient to alter chronic spontaneous seizures in rats (unpublished
findings). However, we recently discovered that specific elements of the AAV9 capsid interact with promoters to
a degree that significantly alters in vivo gene expression (Powell et al., 2020). For example, in the context of the
artificial Jeti promoter the insertion of 6 alanines into aa138 of AAV9 VP1/2 resulted in a 50% increase in neuronal
gene expression (Bohlen et al., 2020). Therefore, we propose that a substantial amount of the clone 83 vector
actually crosses the seizure compromised BBB, but transgene expression is attenuated by an interaction of the
capsid with the promoter. By inserting amino acids into the analogous clone 83 capsid region, we hypothesize
that the increase in in vivo gene expression will prove adequate to exert a therapeutic effect. First the clone 83
AAV capsid will be modified with 6 amino acid alanine insertions into VP1, VP2 or VP1 and 2 at the site analogous
to aa138 of the AAV 9 capsid. Subsequently, these AAV clone 83 capsid variants will be packaged into
recombinant virus that expresses and constitutively secrets NPY[13-36], or appropriate GFP controls. Twenty-
four hours after induction of acute kainic acid seizures, the AAV viruses will be injected intravenously. One week
later, the appearance of limbic seizure activity will be monitored daily for one month. Given that AAV mediated
expression and constitutive secretion of NPY[13-36] significantly blocks kainic acid induced seizures in vivo, we
predict that the increased clone 83 expression will prove sufficient to prevent the development of chronic seizure
activity. Such findings will not only advance clone 83 as an intravenous seizure therapeutic but have significant
impact on the understanding and application of AAV vectors to CNS gene therapies.

Public health relevance
Project Narrative Given a recent discovery, we will modify the capsid sequence of a novel AAV that selectively crosses the seizure compromised blood-brain barrier in order to significantly increase vector mediated anti-seizure gene expression. A successful attenuation of limbic seizure activity after intravenous vector administration would significantly advance gene therapy for the 30% of epileptics who have proven resistant to drug therapy.